The changing face of HIV in the era of COVID-19: Maximising HIV incidence reduction through dynamic targeting of current and future distributions of acquisition risk.

Project Summary
South Africa has the largest HIV epidemic worldwide with 7.8 million people currently living with
HIV. The scaling up of HIV treatment and prevention over the past decade has led to a reduction
of nearly half of new HIV infections and AIDS related deaths between 2010 and 2020.
Notwithstanding this success, our team has presented evidence showing that reduction in new
infections is not homogeneous over time and space and across the age-sex strata. This uneven
risk reduction has led to a shift in the HIV risk landscape resulting in the emergence of new
vulnerable groups. Two major events are likely to cause further changes to the risk landscape.
The first is the shift to Dolutegravir-based antiretroviral treatment regimens. The second is the
disruptions of health services caused by the COVID-19 pandemic creating unprecedented
challenges in HIV care delivery.
Our long-term goal for this proposal is to design the next-generation HIV combination prevention
strategies for poor rural communities in sub-Saharan Africa, which will maximize HIV incidence
reduction through identification and targeting of the most vulnerable sub-groups. We envisage
that early identification of emergent vulnerable subpopulations would become a key element for
an effective programmatic response. Our project will take advantage of one of the largest ongoing
population-based HIV cohorts in the world – the Africa Health Research Institute’s population
cohort in rural KwaZulu-Natal, with individual-level sociodemographic, biological, and clinical data
as well as comprehensive genomics data in the fully integrated individual data platform. The
project will leverage the institute’s existing infrastructure and high-resolution data to (i) Quantify
the shifts in the spatial, temporal and demographic burden of new HIV infections (2022-2026);
and (ii) Harness the changes in the dynamics of the HIV epidemic to design future intervention
programs which will maximize HIV incidence reduction based on the dynamic needs of the most
vulnerable sub-populations.

Public health relevance
Project Narrative Rural KwaZulu-Natal, South Africa is considered to be the epicentre of the global HIV epidemic where the level of new HIV infections remains unacceptably high. Utilising one of the largest ongoing HIV cohorts in the world, we will establish the population shift in the pattern of new HIV infections in rural KwaZulu-Natal South Africa (2022-2026). We will quantify the change in the pattern of new HIV infections in the general population following the shift towards Dolutegravir- based regimens (a new cost-effective drug enabling better treatment adherence) as well as the scaling up new of prevention interventions such as the pre-exposure prophylaxis. We will utilize this information to design future combination intervention programs which seek to maximize HIV infection reduction based on the dynamic needs of the most vulnerable sub-populations.